Reducing Contaminant Exposure through Organic Procurement and On-Site Farm Integration

Project Abstract
Project Title: Reducing Contaminant Exposure through Organic Procurement and On-Site Farm
Integration
The Academy for Global Citizenship (AGC), a public charter school on Chicago’s Southwest
Side, operates as an independent School Food Authority with a self-operated kitchen and full
participation in the National School Lunch Program and CACFP. AGC’s culinary team—
composed of seven full-time, cross-trained staff—prepares scratch-cooked meals daily for all
students, with 75% of offerings anchored in plant proteins and local, humanely raised
ingredients. AGC has a demonstrated commitment to nutrition-forward, equity-centered food
systems and community-rooted wellness strategies.
Through this FDA-funded initiative, AGC will implement two core interventions:
(1) the replacement of daily milk and bread with organic, scratch-made alternatives lower in
glyphosate, and
(2) the integration of produce from AGC’s new on-site 2-acre urban farm—operated in
partnership with Urban Growers Collective—into the salad bar and core menu.
AGC will partner with Wellness in the Schools (WITS) to deliver professional development for
the culinary team via a two-day Cook Camp, implementation consultation, and reporting
support. In-house bread production will follow hands-on workshops and will rely on organic flour
and updated equipment. Expanded labor support will be directed to farm produce prep and
scratch cooking execution.
The project includes a robust evaluation component. From 2020–2023, AGC partnered with
Lurie Children’s Smith Child Health Catalyst to assess shifts in student nutrition knowledge,
behavior, and attitudes. This FDA project builds on that foundation, integrating baseline and
post-intervention contaminant sampling, qualitative feedback from stakeholders, and FDA-
aligned lab testing protocols. Confidential data will be securely stored and managed by the PI
and research team.
The goal is to generate a scalable, replicable model of institutional meal transformation that
reduces contaminant exposure, increases food literacy, and sustains community buy-in for long-
term systems change.

Public health relevance
1 Note: after receiving the following submission error message in era Commons we have submitted our full narrative in ‘Other’ The Project Narrative attachment should not be longer than 2 or 3 sentences. (004.21.2) Project Title: Reducing Contaminant Exposure through Organic Procurement and On-Site Farm Integration The Academy for Global Citizenship (AGC), a public charter school in Chicago, operates a self- run school meal program centered on plant-forward, scratch-cooked meals with locally sourced ingredients. With FDA support, we aim to reduce contaminant exposure by replacing conventional milk and bread with organic options and incorporating produce from our new on- site urban farm. This project will improve student nutrition while contributing meaningful data to the FDA’s food safety and contaminant research.